PREVALENCE OF ATHEROSCLEROSIS AND DIABETES IN AMERICAN SOUTH ASIANS

The purpose of this study is to determine the prevalence of atherosclerotic heart disease, diabetes and lipid disorders in Asian Indian immigrants to the U.S.